Translational Core (Expression Core)

ABSTRACT — CORE B
The mechanisms underlying the development, function, and regulation of regulatory B-cells (Bregs) and
inflammatory B-effector (Beff) cells remain obscure. To date, studies of Bregs and Beff have been challenging
due to their small numbers in clinical samples as well as their heterogeneity. However, the development of
genomic approaches, such as RNA-Seq of bulk populations from low-input samples and single-cell RNA-Seq
(scRNA-Seq) as well as CRISPR–Cas9 genome editing tools, now put this goal within reach. The
Transcriptional and Perturbation Core at the Broad Institute will collaborate with all three projects of the PPG to
profile samples using bulk RNA-Seq, single-cell RNA-Seq, and NanoString technology. We will perform
computational analysis to generate circuit models and identify potential regulators and pathways involved in
Breg and Beff regulation. We will test these predictive models by using CRISPR-Cas9 genome editing
technology in primary cells. The Core will process and analyze samples across all projects and the resulting
data will be shared among all the investigators of the PPG. Overall, these results will lead to better
understanding of Breg and Beff biology, normal function, and their role in disease. It may also potentially lead
to new avenues for therapy for autoimmunity, cancer, and transplant rejection.